AMPHETAMINE INDUCED 11C RACLOPRIDE DISPLACEMENT IN MOOD DISORDERS

To access central dopaminergic function in major depressive disorder (MDD), PET measures of 11C raclopride uptake will be acquired at baseline, after amphetamine (AMPH) induced dopamine (DA) release and following a-methyl-para-tyrosine induced DA depletion in control and depressed samples. The 11C-raclopride uptake in these conditions will provide measure of the baseline dopamine D2/D3 receptor binding, the baseline occupancy of these receptors by endogenous DA and the amount of DA released following AMPH administration in each subject sample. These measures will be compared between depressives and controls to test the hypothesis that MDD is associated with a reduction in ventral striatal DA concentrations.